Facilitating antimicrobial stewardship with an educational video series approach

Diaz-Campos et al.
Vet-LIRN Capacity-Building Project
Facilitating antimicrobial stewardship with an educational video series approach
Abstract
National and international organizations addressing the threat of antimicrobial resistance have
prioritized the education on antimicrobial resistance and stewardship directed to prescribers, other
healthcare providers, and animal owners (patients). Additionally, these organizations recommend
educating each of these groups when implementing antimicrobial stewardship programs. The
expansion of our Ohio State University Buckeye ASP into veterinary private practices in Ohio is
in progress, and one of the core components of our program is education and training. We
hypothesized that the creation and dissemination of educational videos on antimicrobial use,
resistance, and stewardship targeting both lay and scientific audiences will result in more
appropriate antimicrobial use in veterinary medicine and reduce selection pressure favoring
resistant bacterial strains. The aims of this proposal are: 1) to create and disseminate educational
videos on antimicrobial use, resistance, and stewardship topics appropriate for a lay audience
including owners of companion animals; and 2) to create and disseminate educational videos on
antimicrobial use, resistance, and stewardship topics appropriate for a scientific audience including
veterinary medical professionals. We expect to reach out to antimicrobial-prescribers
(veterinarians), other healthcare veterinary providers, and animal owners through the creation of
educational videos medical which will result in promoting the judicious use of antimicrobials and
commitment to other antimicrobial stewardship efforts. These videos will allow us to extend
education and training to people that are not members of our program. In addition, the creation of
these videos will support the mission of the Vet-LIRN network and the CVM-FDA.

Public health relevance
Diaz-Campos et al. Vet-LIRN Capacity-Building Project Facilitating antimicrobial stewardship with an educational video series approach Project Narrative National and international organizations addressing the antimicrobial resistance threat have stated that the education of prescribers, other healthcare providers, and patients or animal owners is a priority and recommend educating these groups when implementing antimicrobial stewardship programs. The Ohio State University Buckeye ASP has been fully implemented in our veterinary medical center and is expanding into private veterinary practices in Ohio. We propose the creation and dissemination of educational videos on antimicrobial use, resistance, and stewardship targeting both lay and scientific audiences to promote the judicious use of antimicrobials and the implementation of other activities in veterinary medicine aiming to support antimicrobial stewardship efforts.